Open Platform for Online Simulations for Stimulating Peripheral Activity to Relieve Conditions - o2S2PARC

IT’IS Foundation, SIM-Core

o2S2PARC – short for Open platform for Online Simulations for Stimulating Peripheral Activity to Relieve Conditions – is the computational platform of the SPARC Data and Resource Center (DRC), developed and maintained by the SPARC Modeling and Simulation (SIM-) Core. o2S2PARC is an interactive platform that allows collaborative development and sharing, model coupling and cloud-based execution of computational models, simulations, data visualization and analysis, and the presentation of results. The platform ensures long-term reproducibility and sustainability of computational studies and workflows and is designed to promote FAIR-ness in the computational modeling community, e.g., by enabling reuse and integration of established models and services without own development skills. On o²S²PARC, code or models can be easily transformed into configurable, reusable, and shareable studies, applications/workflows and services, benefiting from a large number of available modules and from a graphical user interface that is automatically provided. All that is required to access powerful computational resources is a web-browser. The ultimate goal of o2S2PARC is to enable modeling of bioelectronics medicine applications, from device-level physical interactions with the peripheral nervous system/spinal cord through to the resulting therapeutic effects on organ physiology, while also providing advance warning of potential unwanted side effects.

In the coming months, SIM-Core will strengthen the collaborative components of the platform, build developer-centric application programming interfaces (APIs) to facilitate o2S2PARC-based tool/application building, continue to harden and increase the stability and scalability of the platform, establish a framework to facilitate long-term platform sustainability, perform activities to boost platform adoption, and help onboard valuable models from the community. Together with the other DRC Cores, SIM-Core will also engage during year 7 in the development of generalized approaches for capturing (i) population variability, (ii) statistical descriptors, and
(iii) topological maps in the knowledge management system. The infrastructure developed will take the form of services with APIs that can be leveraged by many applications, some of which will be developed by the DRC, while others will be established by SPARC and non-SPARC users. SIM-Core in particular will leverage it to demonstrate the use of SPARC data and o2S2PARC modeling for the generation of regulatory evidence on neural interface safety and efficacy.